Augmented Reality Ultrasound Guidance

SUMMARY
Minimally invasive ultrasound-guided procedures are a mainstay of modern medicine and the number
of such procedures continues to grow. Safe, efficient, and precise execution of these procedures requires
a clear visualization of the target anatomy and the interventional device (e.g., a needle). While sustained
advances in ultrasound technology have led to greatly enhanced visualization of the anatomy and the
needle with high image quality, hand-eye coordination of the practitioner continues to be a challenge.
In order to properly position the interventional device, the practitioner must alternate their attention
between observing the patient, advancing the needle, and viewing the ultrasound image on a separate
screen. Our long-term goal is to develop an advanced visualization platform for ultrasound-guided
procedures to overcome this challenge by greatly simplifying hand-eye coordination. The proposed
platform will be developed using the latest advances in the augmented reality (AR) technology. Through
wearable, see-through AR glasses, the platform will create a virtual display placed in the practitioner's
field of view to show live ultrasound images, registered with the transducer and the patient, in the form
of a hologram. We hypothesize that such visualization will reduce the time of procedure by 20%. Two
specific aims of the project are to: (1) develop augmented reality visualization of live ultrasound images,
and (2) characterize technical performance and demonstrate improved efficiency through user studies.
This project is aimed at providing the practitioner a more intuitive and efficient platform to perform
ultrasound-guided procedures. As these procedures continue to grow, the work is both timely and
essential. Further, the project is innovative because we use AR in a novel way to create a single unified
display. Our multidisciplinary team with a strong track record of pioneering novel image guidance and
AR applications is uniquely qualified for this project. When fully developed, the proposed visualization
platform could make ultrasound-guided procedures safer and more precise and accelerate their growth
by reducing their complexity.

Public health relevance
NARRATIVE Many medical procedures are done with the aid of ultrasound imaging, but they remain difficult to learn and perform. This project will use the advances in the augmented reality technology to make these procedures more intuitive, easier, more precise, and safer.